Mechanisms of S100A9-mediated brain metastasis

Approximately 50% of patients with EGFR-mutant lung cancer develop brain metastasis (BM), which is
associated with poor prognosis and accelerated mortality. There is a long-term unmet need to better define and
target the molecular mechanisms underlying BM in EGFR-mutant lung cancer. We recently identified S100A9
as a key mediator of BM. Our collaborative preliminary studies demonstrate that (i) high S100A9 expression
correlates with aggressive BM and therapy resistance in mouse models and patients with EGFR-mutant lung
cancer; (ii) depletion of S100A9 suppresses BM in mouse models; (iii) expression of S100A9 is epigenetically
driven by both histone lysine methylation and the MEIS1 transcription factor; (iv) S100A9 exhibits a non-
canonical nuclear function that transcriptionally activates pro-metastatic pathways in the brain. Therefore, the
goal of our proposal is to identify potentially targetable up- and down-stream mechanisms of S100A9-mediated
BM to develop more effective therapeutic strategies to treat BM in EGFR-mutant lung cancer. To this end, we
will employ a multidisciplinary approach that leverages the complementary expertise of the Acharyya and Lu
labs, spanning from cancer metastasis biology and modeling to chromatin biology and epigenomics. In Aim 1,
we will test the hypothesis that S100A9 expression in BM-proficient S100A9-high expressing cells is regulated
by the collective actions of histone H3K36 and H3K27 methylation and MEIS1-mediated transcription, using a
combination of epigenome-profiling and -editing technologies. In Aim 2, we hypothesize that S100A9 induces
BM by functioning as a transcriptional activator to drive expression of the pro-metastatic gene CES1, which alters
lipid metabolism. We will employ immunocompetent and patient-derived BM models and slice assays to
investigate how chromatin-bound S100A9 promotes BM through CES1 activation and whether pharmacological
inhibition of CES1 can suppress BM in vivo. Our proposal represents the first study to explore the epigenetic
regulation and nuclear function of S100A9 in BM. These studies are impactful because they will nominate
actionable therapeutic approaches to target S100A9, with far-reaching clinical implications for the development
of effective BM therapies for cancer patients.

Public health relevance
Nearly half of all EGFR-mutant lung cancer patients develop brain metastasis, a severe complication that significantly shortens their survival. We identified S100A9 as a novel mediator of brain metastasis in EGFR- mutant lung cancer. This project proposes to identify potentially targetable up- and down-stream mechanisms of S100A9-mediated brain metastasis for the design of more effective treatments for lung cancer patients.